Institute of Translational Health Sciences

The Institute of Translational Health Sciences (ITHS) has served as the clinical and translational science hub for
Washington, Wyoming, Alaska, Montana, and Idaho (WWAMI) since 2007. The hub brings together 3 top US
research institutions as partners: the University of Washington, Seattle Children’s, and the Fred Hutchinson
Cancer Research Center. The spokes of the hub are academic, clinical, community-based, and other research
organizations across the region. Leveraging networks and relationships built over several years, ITHS will
continue to grow and strengthen our regional Collaboratory, a “center without walls”, to promote research that
improves the health of the people across WWAMI and beyond.
For Workforce Development, there is a strong need for clear career pathways, education, and environments that
support professional growth for clinical and translational researchers (CTR) at all levels. ITHS will expand its
competency-based TL1 predoctoral program in 2 ways: creation of a cohort at a WWAMI university and with a
translational research curriculum to train health professional students during the course of their clinical training.
The Institute will establish competency-based training and career advancement pathways for research staff. We
will provide a learning system that can produce tailored educational content on-demand and at any time.
To enhance Collaboration and Engagement, ITHS will enact team science as an operational standard in CTR,
while cultivating a culture that rewards collaboration in faculty promotion. The Institute will integrate community
stakeholders at all stages of translational research. We will develop a Rural Health Lab handing the leadership
of a research project to a rural community with the aim to tackle a critical community health issue.
Integrating Special Populations in research is a challenge. ITHS will promote the growth of a research workforce
reflective of the communities served, through outreach, funding support, and training that embeds equity
practices into research teams. We will incorporate programs to increase workforce diversity across the Institute.
ITHS will reduce barriers to research participation through integration of remote technologies into clinical studies
and develop best practices to ensure that “teleresearch” reduces rather than amplifies disparities.
Methods and Processes are key to efficiency and quality in research. ITHS supported clinical trials offices have
consolidated key functions under a single umbrella, providing opportunities to streamline research processes.
We will support study metric tracking across a regional research network, enabling organizations to benchmark
performance and collaboratively test and share process improvements. We will develop a pipeline of support for
discovery research to ensure more health innovations reach the clinic.
Informatics and “big data” drive future innovation. ITHS will make clinical data science more accessible,
developing new methods, tools, and education for data exploration, machine learning, and real-world evidence
analysis. We emphasize use of the electronic health record to implement evidence-based guidelines in the clinic.

Public health relevance
The Institute of Translational Health Sciences (ITHS) seeks to improve the quality and efficiency of clinical and translational research across Washington, Wyoming, Alaska, Montana, and Idaho and beyond. The Institute will achieve this goal through education and training, team building, community engagement, continuous process improvement, and advanced informatics.